IGF::OT::IGF AFFYMETRIX AXIOM PILOT FOR NCI (REBBECK) PHASE 1: AFFYMETRIX AXIOM UK BIOBANK 821K AXIOM ARRAY PHASE 2: AFFYMETRIX AXIOM CUSTOM SNP, ITERATIVE DESIGN OF THE MADCAP CUS

AFFYMETRIX AXIOM PILOT FOR NCI (REBBECK) FY 2015 PHASE 1: AFFYMETRIX AXIOM UK BIOBANK 821K AXIOM ARRAY PHASE 2: AFFYMETRIX AXIOM CUSTOM SNP, ITERATIVE DESIGN OF THE MADCAP CUS